Education/Community Outreach Core

PROJECT SUMMARY/ABSTRACT
The goal of the Education and Community Outreach Core (Core C) in our UCSF NCTRI Center renewal proposal
is to continue our structured educational outreach and mentoring program that promotes research in reproductive
sciences, increases scientific literacy, and engages the San Francisco Bay Area community. Core C has
formalized its partnership with four established programs at UCSF: the Science and Educational Partnership
(SEP; high school interns), our departmental Undergraduate Research Internship (URI; undergraduate interns),
the San Francisco State Bridges Program (undergraduate interns) and the San Francisco State-UCSF NIH
BUILD Program (Building Infrastructure Leading to Diversity; undergraduate interns). We will continue to provide
an innovative, formal, intensive summer research and didactic experience that educates and trains students in
various aspects of reproduction research. To promote community involvement in NCTRI activities and to promote
reproductive science literacy in the Bay Area, we highlight student research and other UCSF NCTRI Center
research through public presentations by interns and NCTRI members, and through participation in activities
hosted by the Bay Area Science Festival. All projects and cores will participate in all Core C activities.
Coordination of these teaching and community outreach programs under the aegis of Core C will provide a rich
cross-generational and cross-educational mentoring and teaching experience, will highlight our passion for basic
and translational reproduction research, and will engage the Bay Area community to participate directly in NCTRI
Center activities.

Public health relevance
PROJECT NARRATIVE To have a continuous pipeline of students, scientists, and physicians from diverse backgrounds actively participating in research in reproduction, and to have a scientifically literate population, students at all educational levels and their families must be engaged, educated, mentored and inspired. Core C will engage these communities and will promote activities of UCSF's NCTRI Center through intensive—and fun—summer research in NCTRI laboratories, and will bring these activities back to the community by having students highlight their research in public forums and participating in Bay Area-wide science festival activities.